Timing and regulation of meiotic commitment:Equipment Supplement

Project Summary: The primary goal of our funded research is to understand the molecular mechanisms of meiotic chromosome segregation. An essential tool for the experiments in the funded proposal is the use of time-lapse microscopy. We have two Nikon microscope systems in the lab, but we seek a better way to regulate temperature and humidity for our samples. We are requesting the Tokai Hit STX Stage-Incubation System, with an adaptor to fit our Nikon Ti2 microscope stage, and an objective heater. The Tokai Hit system will maintain a constant temperature and humidity within the chamber to ensure that the experiments are always performed with the same environmental conditions.

Public health relevance
Project Narrative: The funded project will reveal the mechanisms of chromosome segregation during the cell division process of meiosis. I am requesting a Tokai Hit Stage-top Incubation System to control the environment for our time-lapse imaging, which we perform in many of our studies. Our results will be important for public health because they will reveal how errors in meiotic chromosome segregation occur and cause trisomy conditions.